Reduced toxicity allogeneic hematopoietic cell transplantation in malignancies

In this fiscal year, a study of reduced-intensity transplant for patients with peripheral T cell lymphoma has enrolled an arm of the study, with 1 year of follow-up of survivors, and is in the process of being written for publication. The study results have been presented in oral form at the American Society for Transplantation and Cell Therapy. The correlative studies of the project, including the study of horse ATG pharmacokinetics and pharmacodynamics have begun with preliminary data submitted in a successful ASCO Young Investigator Award grant earned by Dr. Kamil Rechache. The peripheral T cell lymphoma study has expanded to enroll patients on a new arm to further study and optimize this novel reduced intensity approach. A new study for patients with hematologic malignancies requiring allogeneic hematopoietic cell transplantation and who are living with HIV has been written and is in the process of IRB review, with the expectation of being open to enrollment by the end of the fiscal year.